Protocol Review and Monitoring System

PROJECT SUMMARY/ABSTRACT – PROTOCOL REVIEW AND MONITORING SYSTEM
The Protocol Review and Monitoring System (PRMS) of the UWCCC provides scientific oversight of all clinical
and translational research conducted in UWCCC. This is achieved through the Protocol Review and Monitoring
Committee (PRMC), which is responsible for evaluating the scientific merit, resource allocation, trial priority,
and trial progress of all new and ongoing cancer-related clinical and translational research protocols. Functions
of the PRMC are complimentary to the Institutional Review Board (IRB), which focuses on the protection of
human subjects, and separate from those of the UWCCC Data Safety Monitoring Committee (DSMC). The
PRMC ensures all trials have appropriate data safety and monitoring plans in place; however, it does not
perform data and safety monitoring functions, which are the responsibility of the DSMC. The PRMC
scientifically evaluates and prioritizes all UWCCC trials derived and supported from institutional sources,
including those originating from other cancer centers or from industry. However, the PRMC does not duplicate
traditional peer review, which includes peer-reviewed protocols supported by the various NIH mechanisms,
other approved funding agencies, and clinical research protocols supported by NCI's Cancer Therapy
Evaluation Program or Cancer Control Protocol Review Committee. The PRMC has the authority to open
protocols that meet the scientific merit and scientific priorities of the center and to terminate protocols that do
not demonstrate scientific progress.
The system for initial review is comprised of a 2-staged review process, starting first with the Disease Oriented
Team (DOT), followed by review by the PRMC. The 2-stage review process is used to increase efficiency by
(1) reducing staff effort in developing protocols and PRMC application materials of lesser scientific merit, (2)
reducing the timeframe from concept approval to protocol activation, and (3) decreasing the volume of
protocols reviewed by the committee, which enables faster and more thorough reviews. In 2016, 344 new
protocols were entered into the PRMS and 168 protocols were approved for activation.